Institutional Career Development Core

The UCSF CTSI's “K Scholars Program” integrates KL2 awardees and other K mechanism/career development
awardees in one of most successful such training programs in the nation. Scholars matriculate with the
methodologic, analytic, leadership, and team science skills required to conduct transformative clinical and
translational research, with a strong track record of attaining research independence. The Program does not
duplicate existing programs at UCSF and is a vital resource for junior faculty from the Schools of Medicine,
Nursing, Dentistry, and Pharmacy. The Program supports Scholars across the entire translational spectrum, with
notable impact in clinical, behavioral, and health services research across the lifespan and for underserved
populations. This renewal focuses on providing emerging skills that will be fundamental to successful careers in
team science-based clinical and translational research, proposing state-of-the-art training in clinical informatics,
data science (DS), and implementation science (ImS). The K Scholars Program will continue to leverage UCSF's
unique strengths and partnerships to extend the impact of the Program by achieving the following Specific Aims:
Aim I.1. To continue to select and train a superb group of UCSF junior faculty KL2 Scholars from diverse
scientific disciplines, and to support them for up to 3 years as they progress toward research
independence. The Program will support a total of 9 KL2 positions (3 new, 3- 2nd year, 3- 3rd year) in each of
the grant years, providing up to 3 years of KL2 funding per Scholar. The Program will continue all of the key
training and mentoring elements of its highly successful K Scholars Program, and enrich further opportunities to
promote research independence and to integrate special populations into clinical and translational research; Aim
I.2. To provide state-of-the-art informatics and DS training, mentorship, and practical experience to
advance clinical medicine and improve public health. An increasingly important goal of much health care
research is to extract knowledge and insights from large and/or complex datasets. This Aim will increase and
facilitate K Scholars' access to new informatics and DS didactic opportunities, along with research consultation
and collaboration opportunities with expert Faculty; Aim I.3. To provide ImS training, mentorship, and
practical experience to accelerate the dissemination of clinical and translational research into clinical
practice and public health. This Aim will train K Scholars to successfully translate scientific evidence into
improved practice, policy, and population health, with a variety of ImS didactic and experiential offerings, along
with research consultation and collaboration opportunities with expert Faculty; Aim I.4. To share and
disseminate the successful elements of the K Scholars Program for local, regional, and national
collaboration. The Program will create new opportunities for UCSF CTSI Scholars and Faculty to interact with
local and regional CTSA partners through activities coordinated through the West Coast Education Consortium.